Activity-based protein profiling of gut microbiota-associated bile acid metabolism

Project Summary/Abstract
The human intestines are colonized by trillions of microorganisms, termed the gut microbiota, which are thought
to rival the number of our own cells. Together, these microbes metabolize small molecules within the intestinal
lumen through the activities of bacterial enzymes that carry out biochemical transformations. Growing evidence
suggests that these small-molecule metabolites confer major benefits to host physiology. However, the enzymes
and biochemical pathways that produce these molecules remain poorly understood.
This proposal seeks to develop chemical approaches to understand the metabolic activity of the gut
microbiome to better understand metabolite production in the gut and how it contributes to health and disease.
The overarching hypothesis guiding this work is that activity-based protein profiling can be used to identify active
bile acid metabolizing enzymes within the gut microbiome, which produce secondary bile acids that have critical
functions in physiology and disease, and to identify bacterial proteins regulated by bile acids that play important
roles in microbial metabolic crosstalk. We will address this hypothesis with the following studies:
Develop chemical probes for identifying active bile acid metabolizing enzymes. Building on our
systems biochemistry approach, we will develop activity-based probes to target important enzymes in secondary
bile acid metabolism within the gut microbiota. These studies will globally identify individual gut bacteria that are
actively producing bile acid metabolites, which cannot be addressed with traditional biochemical approaches.
Characterize bacterial proteins that utilize or are regulated by bile acids. We will apply these
chemical probes to identify bacterial proteins that are bile acid interacting proteins and characterize the roles of
bile acids in regulating their activities. These results will advance our understanding of metabolic crosstalk
between gut bacterial pathogens and commensal bacteria.
Visualize gut microbiota-associated bile salt hydrolase activity in health and disease. We will apply
the chemical probes to image active bile acid metabolizing enzymes within the intestinal tissue from mice in both
health and disease. These studies will determine the localizations of gut bacterial niches that are actively
metabolizing bile acids during gut epithelial damage and inflammation that are affected by maladaptive changes
to gut microbial composition.
Current technologies based on metagenomics are limited in their ability to report on genes that are
present within the microbiome. Our chemical approach will define how activities of enzymes within the gut
microbiome carry out metabolism of important small-molecule metabolites that regulate host physiology and
pathology. Broadly, our tools will contribute to a deeper understanding of host-gut microbiota interactions and
how this complex relationship influences human health and disease.

Public health relevance
Project Narrative The human gastrointestinal tract is colonized by up to 100 trillion commensal microorganisms, termed the gut microbiota, which are known to influence host immunity and physiology through their metabolic activities. However, the biotransformations carried out by these bacteria remain poorly characterized at the enzymatic level, including which enzymes are active and how their activities influence microbial metabolic pathways. This research will ultimately provide a mechanistic basis for the development of therapeutics and prophylactics for diseases that are regulated by the gut microbiota, including inflammatory bowel disease (IBD), cancer, allergy, and metabolic syndrome.